Phosphatidylserine signaling in neuronal refinement of the cochlea

ABSTRACT
Hearing loss is one of the most common disabilities in the United States and understanding how the inner ear
develops and establishes proper communication with the brain will provide invaluable knowledge that can help
us generate interventions for human hearing loss. Two types of hair cells are responsible for unique cochlear
functions: inner hair cells (IHCs) receive 95% of the afferent innervation by spiral ganglion neurons (SGNs),
whereas outer hair cells (OHCs) are involved in cochlear amplification and also establish limited afferent
connections with type II SGNs. As in general nervous system development, during cochlear development, a
notable phase involves the initial abundance and subsequent pruning of spiral ganglion neurons (SGNs) and
synapses before the onset of hearing. The pathways that mediate this pruning process are a topic of active
investigation. We propose that after excessive innervation, SGNs with functional synaptic connections are
labeled as “active” and retained, while SGNs with weak synaptic connections are labeled “inactive” and marked
for removal. Phosphatidylserine (PS) has been robustly identified throughout the literature as a prime “eat me”
signal in the context of apoptosis and increasingly within synaptic pruning and neuronal remodeling. Therefore,
the central hypothesis of this proposal is that the presentation of PS marks inactive OHC-SGN connections and
labels them for removal by a yet unknown phagocytic mechanism. This hypothesis is supported by multiple lines
of evidence generated in my preliminary studies: I first showed that ATP8A2, a lipid flippase known to clear PS
from the exterior leaflet of the cell membrane, is specifically localized to OHCs and type II SGNs during the
pruning period. Furthermore, in a mouse line that expresses a hypofunctional variant of ATP8A2, which was de
novo generated and characterized in my preliminary studies, the synaptic connection between OHCs and type
II SGNs are impaired. Based on these findings, my specific hypothesis is that active OHC-SGN axes express
ATP8A2 and thus clear any presentation of PS on the outer leaflet of the cell membrane which ultimately allows
ATP8A2-expressing cells to survive. This hypothesis will be tested in two specific aims (SAs). In SA1, I will test
the hypothesis that ATP8A2 is necessary for proper pruning of type II SGNs, and that ATP8A2 localizes to SGNs
in an activity-dependent manner to prevent PS externalization. In SA2 I will identify the cell types that recognize
PS and explore the mechanism by which they facilitate pruning. This work will help elucidate the cellular and
molecular mediators of cochlear pruning.

Public health relevance
PROJECT NARRATIVE This proposal will describe a previously unknown mechanism of postnatal neuron and synapse pruning in the mammalian cochlea. Data generated from these experiments will build upon our knowledge of the function of both membrane dynamics and supporting cells in postnatal cochlear development. Understanding this process could provide insight into the prevention of hearing loss, which affects approximately 1 in 5 people worldwide (World Health Organization World Report on Hearing).